The molecular mechanism linking respiratory NADH oxidation and virulence in Staphylococcus aureus

ABSTRACT
Staphylococcus aureus infections are a major cause of morbidity and mortality in the United States and across
the globe. This is largely due to the evolution of multidrug-resistance and the ability of the bacterium to adapt
its metabolism and bioenergetics to infect nearly every site of the human body. Thus, there is a significant
need for the development of effective therapeutics against this organism. There are several critical gaps in our
knowledge of how metabolic pathways used by S. aureus in different environments influence this pathogen
virulence in vitro and inside the host. Therefore, our long-term goal is to elucidate how S. aureus receives
signals from the environment in the host (e.g. oxygen concentration, nutrients), senses its own redox poise and
energy status, and triggers metabolic changes, including the production of virulence factors.
Our previous studies identified two respiratory enzymes in S. aureus called type 2 NADH dehydrogenases
(NDH-2s: NdhC and NdhF) and revealed their importance for animal infection and organ colonization, and the
production of virulence factors and biofilm formation in vitro. These results lead to our central hypothesis that
the NADH-dependent respiratory chain is primarily responsible for controlling the NADH/NAD+ and MQH2/MQ
(menaquinol/menaquinone) pools that are used by the cell to monitor its redox status and which we propose
are major elements regulating virulence via specific global regulators. Guided by strong preliminary data, we
propose to pursue three Specific Aims: (1) Determine the metabolic pathways utilized both in the presence
and absence of each of the two NADH dehydrogenase enzymes, and the molecular mechanisms by which
these enzymes modulate the production of α-toxin; (2) Determine why the presence of both NADH
dehydrogenase enzymes is important for biofilm formation; (3) Determine if menaquinol is the signaling
molecule that directly induces SrrB and SaeS autokinase activity in the SaeRS and SrrAB two-component
systems, which are both critical for the regulation of virulence and biofilm formation. To accomplish these Aims,
we have assembled a powerful team to employ a multidisciplinary approach that combines metabolomics,
proteomics, genetics, microfluidics technology and biochemistry.
Collectively, our proposed studies will have a broad impact on the field by uncovering the role of the
respiratory chain in connecting environment signals with the intracellular redox poise that regulates S. aureus
virulence. In the long term, these studies may reveal novel therapeutic targets to treat S. aureus-related
diseases.

Public health relevance
NARRATIVE Staphylococcus aureus is one of the most dangerous and costly bacterial pathogens in the United States. This proposal will uncover the mechanism by which the respiratory metabolism regulates virulence and advance our understanding on the adaptive mechanisms that enable this organism to be such a versatile pathogen.